Molecular regulation of stress sensing and processing in gram-positive and gram-negative bacterial models.

PROJECT SUMMARY
Bacteria use a remarkable array of responses to effectively survive and compete in ever-changing
environmental and internal conditions. To do so, they must sense environmental or internal cues and then
enact an appropriate response. Bacterial sensing impacts human health; for instance, stress-responding
bacteria can be recalcitrant to antibiotic therapy, and some 100,000 Americans die each year from infections
with antimicrobial-resistant bacteria. Bacterial responses can also impact other competing bacterial cells in the
same niche, even killing them. We seek to learn more about these responses so that we can devise
antimicrobial treatment strategies that either interfere with stress sensing or hijack bacterial response
mechanisms to kill pathogens. Our research program uses two distinct bacteria—the classic model Bacillus
subtilis and the notorious opportunistic human pathogen Pseudomonas aeruginosa—to tackle fundamental
questions about the molecular components that undergird cue-sensing and control the corresponding
responses. In B. subtilis, we have a special focus on the dynamics of environmental stress responses in single
cells, asking how particular proteins impact response dynamics and how such dynamics influence cell growth
and survival under stressful conditions. In P. aeruginosa, we mainly focus on the molecular regulation of
pyocins, which are released by dying cells and can effectively kill other P. aeruginosa strains. In both projects,
we have an eye toward leveraging stress sensing and pyocin production to improve antimicrobial therapy. We
also study regulatory pathways and proteins that respond to important nutritional cues and influence virulence
behaviors. In the questions we ask, we seek to understand the molecular interactions that connect internal or
external cues to responses that confer competitive or fitness advantages. Using these tractable models, we
bring together classical bacterial genetics, molecular techniques, fluorescence microscopy, and microfluidic
technology. We anticipate these studies will yield a new and more mechanistic understanding of the principles
that govern how bacterial cells sense internal and external cues, process those sensory inputs, and implement
an effective response. The results, which flesh out the principles of the diverse systems under investigation,
will have implications for understanding general features of systems that respond to stress or other responses
across many biological systems as well as informing future strategies that counteract bacterial infectious
disease and environmental contamination.

Public health relevance
NARRATIVE Bacteria sense and respond to a remarkable range of environmental and internal cues, from nutrients and stressors to cellular damage, thanks to sophisticated molecular systems that sense cues and connect them to appropriate responses. A deeper understanding of these systems will facilitate efforts to control unwanted microbial growth, whether in infections or in the environment. This project uses two different bacterial species with the goal of elucidating the molecular pathways and principles that govern cue sensing and understanding how sensory signals are processed and interpreted to enact responses that maximize cell survival and fitness.